Structure and Function of Tau Protein

The microtubule associated protein tau is essential for the development and maintenance of the nervous system. On the other hand, tau hyper-phosphorylation and dysfunction have long been correlated with Alzheimer's disease and a number of related dementias. Recent genetic evidence extended these correlations, demonstrating that mutations affecting either the primary structure of tau or the regulation of tau RNA alternative splicing can cause FTDP-17, a collection of neurodegenerative disorders with many similarities to Alzheimer's disease, including abnormal tau fiber formation, neuronal cell death and dementia. Additional biochemical and genetic data support the conclusion that pathological tau action is likely a key component in Alzheimer's, FTDP-17 and additional "tauopathies". Therefore, gaining a thorough understanding of normal and pathological tau action is of fundamental importance. Mechanistically, tau serves at least many of its functions by regulating the growth and shortening dynamics of microtubules. Since proper regulation of microtubule dynamics is well-established to be essential for cell function and viability, neurons exert tight control over tau action. Indeed, tau activity is regulated by both alternative splicing of tau RNA and phosphorylation mechanisms. In the previous cycle of this project, we performed a detailed mechanistic analysis of the abilities of normal and FTDP-17 mutant tau isoforms to regulate microtubule dynamics, leading us to propose a mis-regulation of microtubule dynamics model in which properly regulated tau maintains MT dynamics within a defined range of tolerable activities whereas errors in tau action lead to inappropriate regulation of MT dynamics, which in turn leads to neuronal cell death and dementia. Here, we propose to superimpose phosphorylation mediated effects upon tau's ability to regulate microtubule dynamics in order to test the hypothesis that biologically relevant but inappropriate phosphorylation of tau compromises its ability to properly regulate microtubule dynamics, thereby promoting cell death. We will also test the hypothesis that inappropriate phosphorylation of tau exacerbates the FTDP- 17 mutation induced inability of tau to properly regulate microtubule dynamics, again promoting neuronal cell death. We will focus our efforts upon CDK/p25, GSKSp and MARK, three kinases with well-established in vivo relevance for tau as well as Pin1, a prolyl isomerase involved in regulating tau phosphorylation and strongly implicated in neurodegeneration. Briefly summarized, this proposal seeks to better understand the precise details underlying neuronal cell death leading to dementia. Achieving this goal will provide excellent potential targets for the development of rationally designed anti-dementia therapeutics.